Therapeutic Interventions to Access Outcomes and Disparities in Chronic Kidney Disease Among Veterans

Chronic kidney disease (CKD) affects approximately 10% of the general population and is especially common
among US veterans, affecting up to 36% of all VA users during FY2006-2014. All-cause and cardiovascular
(CV) morbidity and mortality are extremely high in veterans with CKD and ESRD, and African American
veterans have substantially higher rates of CKD and CV disease than whites. Traditional risk factors of
cardiovascular disease such as hypercholesterolemia, hypertension and obesity often show seemingly
anomalous, inverse associations with adverse outcomes among individuals with CKD and ESRD. To date
there are few therapeutic interventions proven to prevent the development of CKD, delay its progression, or
decrease morbidity/mortality in patients with CKD. There is also a lack of race-specific application of clinical
interventions, in spite of evidence suggesting that African-Americans may respond differently to various
therapies. The lack of clinical end point driven randomized controlled trials in this population necessitates
robust epidemiologic studies to provide preliminary results in support of future clinical trials, and to offer large-
scale, widely applicable evidence to inform clinical practice in cases when clinical trials are not feasible. Our
proposal will expand on our previous work using data obtained from the national VA research database, which
offers uniquely detailed sociodemographic and clinical information on millions of individuals across all parts of
the US.
The Specific Aims of our proposal are:
Aim 1: Examine the effect of interventions on clinical outcomes in veterans with non-dialysis dependent CKD
(NDD-CKD) overall and by race-ethnicity.
Aim 2: Examine the effect of interventions on incident CKD and on all-cause and cause-specific mortality,
CHD, incident stroke and incident CHF in veterans with normal baseline estimated GFR, overall and by race-
ethnicity.
Aim 3: Employ powerful graph theoretical algorithms and scalable supercomputer implementations to test and
extend the validity of the findings from Aims 1 and 2, and to help elucidate hidden factors and highlight
previously unknown relationships between condition, risk, treatment and outcome.
Next steps: This four-year project will generate a wealth of information to examine the above outcomes of
patients with all levels of kidney function, and could have significant implications for the care of US veterans
and also for patients with kidney diseases in general. Clinicians and guideline committees could use
information generated from our research to determine the most likely benefits for interventions without clinical
trial evidence, and this could help prioritization of healthcare expenditures and drug formularies. Clinical
trialists could also use information generated from our research to determine likely effect sizes for various
interventions and various subgroups that may be most prone to benefit from interventions. Furthermore,

Public health relevance
Chronic kidney disease is very common among US veterans and is associated with high morbidity, mortality, and healthcare costs. The proposed research will result in the identification of interventions with potentially significant effects towards preventing CKD in the general VA population and/or decreasing mortality and clinical events among veterans with established CKD, overall and in racial minorities. These results are critical for primary and secondary prevention efforts to reduce the risk and impact of CKD, especially in high-groups such as racial minorities.